Mechanisms of Synaptic Homeostasis Governing Pre-Sympathetic Neurons in the Hypothalamic Paraventricular Nucleus

Project Summary
Pre-sympathetic neurons (PSNs) of the hypothalamic paraventricular nucleus (PVN) are essential drivers of
physiological and pathological increases of sympathetic nerve activity (SNA). Perhaps their most robust property is
their resting state of discharge quiescence. Early studies linked quiescence to the dominance of synaptic inhibition,
but mechanisms that establish and defend GABAergic inhibitory tonus in the PVN are understood only on a
rudimentary level. This is an important knowledge gap because pathogenic factors that increase PVN-driven SNA
must ultimately subvert or overwhelm mechanisms that regulate the quiescent resting state of PSNs. In preliminary
studies, we uncovered a presynaptic mechanism that is novel to the PVN, referred to as “Glutamate-GABA
strengthening (GGS)”, that increases GABAergic inhibition in pace with synaptic glutamate (Glu) spillover. To do so,
GGS regulates the amplitude of GABA-A receptor-mediated inhibitory postsynaptic currents (IPSCs) through uptake
of synaptically released Glu, ostensibly into local GABA terminals, by the neuronal excitatory amino acid transporter
3 (EAAT3). Once internalized, Glu is converted to GABA and GABA molecules are packaged into synaptic vesicles
at greater than normal density. Stressors that acutely increase PVN-driven SNA are hypothesized to increase
synaptic Glu release without changing extrinsic GABAergic input. As a result, “over-filled” GABA vesicles are
released that dampen excitation and aid restoration of PSN quiescence. During chronic sympathoexcitation
challenges accompanied by reduced GABA input, GGS is subverted (due to low GABA release) and can therefore
provide little opposition to synaptic excitation. Proposed studies will use state-of-the-art transgenic mouse models,
optogenetics and virus-mediated gene over-expression and CRISPR-Cas9 knockdown to assess mechanisms and
functional outcomes of GGS. Kinetics, sensitivity and efficacy of GGS will be established at the single PSN level
using a novel horizontal brain slice preparation that preserves Glu input from the forebrain median preoptic nucleus
(MnPO) as well as GABA input from the PVN peri-nuclear zone (PNZ). Retrogradely transported AAV will be injected
into the PVN of vGlut2-Cre mice to express channelrhodopsin (ChR2) in glutamatergic MnPO-PVN neurons.
Optogenetic activation will determine the capacity of MnPO inputs to drive GGS amongst RVLM-projecting PVN
PSNs. Using vGlut2fl/fl mice, we will determine functional effects of GGS on GABA-A receptor inhibitory tone and
SNA responses to forebrain angiotensin II (AngII) and hyperosmolality when glutamatergic MnPO neurons have
normal (vGlut2 intact) or diminished (vGlut2 knockdown) capacity to release Glu from PVN synapses. To further
illuminate in vivo mechanisms and efficacy of GGS, EAAT3 on PNZ GABA inputs to the PVN will be increased and
decreased to grade PVN GABAergic tonus and the magnitude of PVN-driven SNA responses to (1) acute forebrain
AngII and hyperosmolality as well as (2) sub-acute water deprivation and high salt intake. Proposed studies will
provide unprecedented mechanistic insight into the physiological role GGS plays in generating and defending
PVN PSN quiescence, and are essential for advancing the goal of preventing and reversing disease-promoting
sympathoexcitation.

Public health relevance
Dysfunction of pre-sympathetic neurons in the hypothalamic paraventricular nucleus (PVN) is implicated as a potentially causal factor in major cardiovascular and metabolic diseases in which sympathetic nerve activity becomes chronically elevated. A large and rapidly expanding number of factors has been implicated in autonomic dysfunction, but there is presently little evidence from which to generate specific hypotheses for how these pathogenic factors disrupt the normal balance of synaptic excitation and inhibition in the PVN. Proposed studies will provide new and potentially important insight into the basic mechanisms that generate and dynamically defend the strength of synaptic inhibition by GABA, which normally ensures that PVN neurons are held nearly quiescent in the unstressed animal. Pathogenic mechanisms that activate PVN pre-sympathetic neurons must subvert or overwhelm these fundamental mechanisms of synaptic homeostasis in order for sympathetic nerve activity to become chronically elevated.